FDA Vet-LIRN Cooperative Agreement with Ohio ADDL to support projects and work associated with One Health, animal food issues, antimicrobial resistance, and surge capacity testing.

FDA CVM Vet-LIRN PROGRAM PROPOSAL
FOR FOA PAR-23-202
“FDA Vet-LIRN Network Capacity-Building Project and Equipment Grants”
ABSTRACT
This proposal from the Ohio Department of Agriculture (ODA) is in response to Funding
Opportunity Announcement (FOA) PAR-23-202 from the Food and Drug Administration’s (FDA)
Center for Veterinary Medicine (CVM) Office of Applied Science's Veterinary Laboratory
Investigation and Response Network (Vet-LIRN). The project is titled “FDA Vet-LIRN Cooperative
Agreement with Ohio ADDL to support projects and work associated with One Health, animal food
issues, antimicrobial resistance, and surge capacity testing”.
This proposal from ODA’s Animal Disease Diagnostic Laboratory (ADDL) addresses the following
key project areas:
1. Supporting the development, adaptation, or verification/validation of new methods
associated with animal food issues or antimicrobial resistance.
2. Short-term monitoring efforts aligned with the CVM mission.
3. Supporting equipment for testing or developing tests associated with animal food-related
issues or antimicrobial resistance, including those for emerging technologies.
4. Developing projects related to antimicrobial stewardship, in alignment with CVM's key
initiatives in this area.
5. Contributing as part of Vet-LIRN's antimicrobial resistance (AMR) monitoring program,
including sequencing isolates.
6. Supporting work associated with One Health, including emerging diseases such as
COVID-19, when funding is available.
7. Support emergency surge capacity testing during large-scale animal food/feed emergency
events requiring testing of implicated diagnostic or animal food samples
The ADDL is also poised to address new developments in emerging regulatory sciences as well
as urgent or novel areas for potential research. The laboratory’s certificate of AAVLD accreditation
is provided as part of this proposal to showcase the laboratory’s ability to provide the capacity
and capability to conduct the project. We are confident that we can meet the objectives of this
project and look forward to the opportunity to work with the FDA.

Public health relevance
FDA CVM Vet-LIRN PROGRAM PROPOSAL FOR FOA PAR-23-202 “FDA Vet-LIRN Network Capacity-Building Project and Equipment Grants” NARRATIVE This Veterinary Laboratory Investigation and Response Network (Vet-LIRN) capacity building project strengthens the capacity, collaboration, and integration of food-safety laboratories and networks, thereby facilitating an effective and coordinated response to future human and animal food safety issues. The Vet-LIRN at the U.S. Food and Drug Administration (FDA) and Animal Diseases Diagnostic Laboratory at the Ohio Department of Agriculture (Ohio ADDL) will collaborate to perform whole genome sequencing (WGS) of foodborne pathogen isolates. This project will support the identification and adoption of emerging technologies and the harmonization of analytical methods used by equipment platforms for antimicrobial resistance (AMR) studies.